Metabolite Transport Modulation to Mitigate Ischemic-Reperfusion Injury

Project Summary/Abstract
This proposal investigates metabolite transport modulation in the setting of myocardial ischemic-reperfusion (I/R)
injury. I/R is a consequence of the standard of care for heart attack patients and leads to heart failure (HF). The
overall aim of this grant is to develop novel interventions to mitigate injury to the heart by focusing on metabolite
transport modulation. The experiments focus on the inhibition of monocarboxylate transporter 4 (MCT4), which
is crucial for lactate excretion, and potentially other metabolites from cardiomyocytes. My previous research has
shown the potential for cardioprotection with MCT4 inhibition. The four specific aims that are proposed in this
grant are as follows:
K99-Aim 1: Define metabolite transport and utilization in response to I/R with and without MCT4
inhibition in vitro.
K99-Aim 2: Determine metabolite transport in vivo during I/R injury with MCT4 inhibition.
R00-Aim 1: Test whether MCT4 inhibition is sufficient to protect against development of ischemic
cardiomyopathy.
R00-Aim 2: Determine roles for MCT4 inhibition in preserving human myocardium in ex vivo injury
models.
By uncovering how MCT4 inhibition influences myocardial biology, my research offers a therapeutic approach to
alleviate cardiac injury. Continued training will add new dimensions to my knowledge base that will be broadly
applicable to my goal of leading a lab at a top-tier research institution studying protection from cardiovascular
diseases (CVD). These avenues of research have the potential to alter our understanding and approaches to
cardiovascular medicine, and my long-term vision is to develop novel approaches in the fight against CVD that
will improve quality of life. To accomplish this, I have a team of supportive faculty mentors who are experts in
cardiovascular and metabolism research. The UofU has exceptional researchers who collaborate through
institutional organizations such as the Nora Eccles Harrison Cardiovascular Research & Training Institute and
the Diabetes and Metabolism Research Center. This award is foundational for my scientific career, bridging in-
depth research with practical, clinical utility in cardiovascular medicine. These experiments will lay the
groundwork for new therapeutic approaches during cardiac injury. Under the guidance of my co-mentors and my
team of collaborators during this K99/R00, this grant will allow me to eventually transition seamlessly from my
current mentored position into an independent research group leader at an R1 institution.

Public health relevance
Project Narrative This research is pivotal for public health as it addresses the critical challenge of ischemic-reperfusion (I/R) injury in patients suffering from a “heart attack” or acute myocardial infarction (AMI), a prevalent condition with high mortality rates. By exploring innovative therapeutic strategies centered on metabolite transport modulation, this study aims to alleviate I/R injury, thus potentially reducing the incidence of chronic heart failure and improving the life expectancy and quality of life for heart attack survivors. The research approach holds significant promise for enhancing clinical practices and mitigating the substantial healthcare costs associated with post-AMI care.